Core A: Administrative

PROJECT SUMMARY – CORE A
The overall goals of this PPG are to define the mechanisms that lead to increased incidence of hepatocellular
carcinoma (HCC) with age and to leverage this understanding to develop and validate candidate approaches for
enhanced early detection and prevention. To achieve these Goals requires an interdisciplinary team of experts,
specializing in different molecular and cellular aspects of both cancer and aging biology, innovative mouse
models and experimental tools, and Core facilities to maximize efficiencies and promote synergies. In turn, this
multi-pronged team requires an Administrative Core to support and orchestrate its activities.
Profs. Peter D. Adams (Sanford Burnham Prebys Medical Discovery Institute (SBP), La Jolla) and Gerald S.
Shadel (Salk Institute, La Jolla) will serve as multiple PD/PIs, with Adams serving as the Contact PI. Shadel will
lead Project 1 and Adams Project 2. Other Project Leads are Prof. Susan Kaech (Salk Institute, La Jolla; Project
3) and Prof. Gen-Sheng Feng (University of California, San Diego (UCSD); Project 4). The P01 also incorporates
three Cores, an Administrative Core A (Leads Shadel and Adams), a Mouse models of aging and cancer Core
B (Lead Dr. Alessandra Sacco, SBP) and an Integrated bioinformatics of aging and cancer Core C (Lead Dr.
Maxim Shokhirev, Salk Institute). Kaech, Feng, Sacco and Shokhirev are all very accomplished scientists and
highly qualified to lead their components and to contribute to overall leadership of the PPG. This 6-member
Executive Team will direct the Specific Aims of this Administrative Core. Tasks will be executed by a dedicated
Administrative Coordinator for the P01. Ultimate responsibility for making decisions will be the joint responsibility
of Shadel and Adams, as outlined in the Multiple PD/PI Leadership Plan.
The Specific Aims of this Administrative Core are as follows.
Specific Aim 1. Facilitate the research Objectives of the P01. Specifically, Core A will make available facilities
and resources to projects and cores; facilitate training; arrange meetings and annual on-site retreat; arrange
EAB meetings; conduct Project and Core evaluation; advocate for Projects and Cores, as necessary.
Specific Aim 2. Facilitate interactions and collaborations within and external to the P01 Specifically, Core A will
facilitate interactions and collaborations between projects and cores; promote resource sharing between projects
and cores; present the external face of P01 to the scientific community at large.
Specific Aim 3. Ensure regulatory compliance of the P01 Specifically, Core A will be responsible for fiscal
management; regulatory compliance, including mice and use of human tissues; timely submission of progress
reports; data and resource sharing; protection of intellectual property.